TONSILS: AN UNRECOGNIZED ROLE IN INFLUENZA VIRUS EVOLUTION

Identifying the host factors that contribute to influenza virus (IV) pathogenesis are critical for disease control and preventing
pandemics. The tonsils comprise 2 lymphoid organs located in the nasopharynx of mammals and in the cecum of birds, in
which IVs are enteric. The tonsils are an initial site of various viral infections and transmission, but their role in IV
pathogenesis is unclear. My proposed studies will provide new insights on how the tonsils contribute to IV pathogenesis,
immune responses, and adaptation by identifying the role of the tonsils in IV pathogenesis, performing tonsillectomy in
ferrets to recapitulate the heterogeneous responses to IV infection severity and vaccination in subpopulations of humans
with/without tonsils, and exploring the role of the tonsils in IV adaptation. My recent study demonstrated that human
tonsillar epithelial cells (HTECs) are susceptible to IV infections, with effective replication of different IV subtypes in vitro.
I will expand upon these findings by performing time-intensive monitoring of IV infection dynamics and distribution in the
tonsils of ferrets. I collected and analyzed human tonsillectomy data over the last 60 years in the US and found that the
percentage of human subpopulations with tonsillectomies is high in different age groups. The prevalence, disease severity,
and level of immunity of IV infections in these subpopulations are unknown, and the role of the tonsils in epidemic or
pandemic spread of IVs is undetermined. I previously found that HTECs induce chemokine and cytokine release during IV
infection. Previous clinical studies reported no differences in salivary IgA immune responses to IV live attenuated vaccine
in individuals before and after tonsillectomy, but these studies were limited by low patient numbers and confounded by
original antigenic sin. I will use ferrets to ascertain how tonsillectomy affects immunity resulting from the IV infection and
vaccine. I will measure the quantity and quality of antibody responses after infection and/or immunization and compare T-
cell and B-cell activity in ferrets with and without tonsils. The soft palate is an important site of IV adaptation, extending
downward in the oral cavity and passing anterior and posterior to the tonsils. The replicative fitness of IVs in tonsillar tissues
may induce rapid selection, ostensibly preventing infection and reducing their pandemic potential. Therefore, I propose to
verify the role of the tonsils in IV adaptation a tissue not typically sampled in animal models of IV and investigate the extent
of different human IV replication in the tonsils. Acquiring mutations and switching receptor-binding specificity between
avian and human sialic acid (SA) preferences are key for IV transmission and adaptation. I previously found that both human
and avian tonsil epithelial cells are rich in both human α2,6 and avian α2,3–linked SA receptors and support IV replication.
I will use genetically engineered IVs with altered SA preferences to conduct transmission studies and analyze the viral
fitness within the tonsils that may select for transmissible IVs more rapidly than the soft palate by using a loss-of-function
approach. The mentored phase of this proposal will occur at St. Jude Children Research Hospital under the auspices of
Richard Webby and will elucidate the role of the tonsils in IV pathogenesis and immune responses to infection. The
independent phase will focus on immune responses to IV vaccines and IV adaptation. The institutional resources, academic
environment, and educational opportunities outlined in my proposal will ensure my successful transition to independence.

Public health relevance
Project Narrative Influenza viruses (IVs) continuously jump species barriers, causing new human infections and pandemics. Analyzing the replicative fitness of IVs in yet-unrecognized tissues such as the tonsils is critical to prevent future IV infections and pandemics in a timely manner. This proposal will elucidate the contribution of the tonsils to the pathogenic mechanisms underlying initial IV infection and adaptation in mammals in the following ways: studying the role of the tonsils in immune responses, modeling tonsillectomy in ferrets, ascertaining how tonsillectomy as a host variable affects the diverse outcomes and heterogeneous immune responses of IV infections and vaccines in people, and determining the role of the tonsils in IV adaptation and evolution.